2023 Stem Cells and Cancer Gordon Research Conference and Seminar

PROJECT SUMMARY
This proposal requests partial support for the eighth Gordon Research Conference on Stem Cells and
Cancer, which will take place on May 14-19, 2023 in Lucca (Italy). The goal of this conference is to provide a
forum for presentation, discussion and interaction among a diverse, interdisciplinary group of researchers with
interests in stem cell biology, development, and cancer. In particular, we wish to highlight how principles taken
from development can be used to better understand tumor initiation and metastasis. The meeting is chaired by
Dr. Cedric Blanpain (Université Libre de Bruxelles), with Drs. Leanne Jones (UCSF) and Kathrin Plath (UCLA)
serving as vice chairs. The planned agenda includes presentations from key leaders in the fields of cancer
biology, stem cell biology and regenerative medicine, and thus will attract a highly interdisciplinary group of
researchers who do not frequently interact at meetings. This meeting will, therefore, act as a catalyst for new
collaborations and cross-fertilization of ideas, which is, of course, a long-term goal of the Gordon Research
Conferences. The outstanding scientific program for the meeting highlights the diversity of contributors to this
research area (48% of invited speakers are female and/or members of under-represented minority groups) and
explores cutting-edge topics of particular interest to the National Institutes of Health (NIH), including but not
limited to: developmental mechanisms known to regulate stem cell fate decisions and tissue homeostasis that
are usurped for tumor formation, the role of metabolism in regulating stem cells, tissue homeostasis and tumor
growth, and emerging therapies to promote tumor cell clearance, eradicate tumor-propagating stem cells and
enhance organ repair. Additional speakers will be chosen from the submitted abstracts, with particular
consideration given to those investigators from backgrounds traditionally underrepresented in the sciences. The
2023 Gordon Research Conference on Stem Cells and Cancer will also include a Gordon Research Seminar
(GRS), a 2-day “pre-meeting” of early career scientists in a highly stimulating and inclusive environment that
promotes the open exchange of information and establishment and growth of peer networks. The GRS will be
held from May 12-13, 2023 at the same venue in Lucca, and is chaired by Dr. Tugba Topal (Univ. of Michigan)
and supported by an organizing committee of three doctoral students: Clara Cano (UCLA), Andrea Pérez
González (Université Libre de Bruxelles), and Nicholas Jackson (UCSF). The GRS provides additional
opportunities for junior trainees to present their work and receive crucial feedback and mentorship both from
their peers and from more established investigators, making this meeting a particularly valuable training
opportunity for junior investigators. The specific set of integrated and complementary research topics that will be
addressed in the 2023 Stem Cells and Cancer GRS/GRC is distinct from other conferences, and the unique
structure of the GRS and GRC provides for productive interactions among scientists and trainees at different
career stages in industry and academia who are addressing fundamental questions in the area using different
experimental approaches.

Public health relevance
PROJECT NARRATIVE The 2023 Gordon Research Conference (GRC) and Gordon Research Seminar (GRS) on Stem Cells and Cancer will enhance our understanding of the overlapping strategies used to regulate stem cell behavior in the context of development and cancer stem cells in tumor initiation and progression. The unique structure of the GRS and GRC provides for productive interactions among scientists and trainees at all career stages, in industry and academia, who are addressing fundamental questions related to Stem Cells and Cancer using different experimental models and approaches. Support for this conference will directly contribute to new discoveries regarding strategies for detection of cancer stem cells and therapeutic approaches to target tumor cell growth and cancer metastasis, leading to eradication of cancer stem cells and improved patient prognosis and care.